Using Performance Feedback and Facilitation to Integrate Motivational Interviewing in Teen Helpline Services

PROJECT SUMMARY/ ABSTRACT
The resubmitted proposed K23 Mentored Patient-Oriented Research Career Development Award will
provide the applicant with advanced training and skills to launch an independent research program to improve
service disparities among youth from underserved backgrounds, by developing and evaluating hybrid
effectiveness- implementation trials within helpline settings. The proposed K23 project begins to establish a
foundation for research within helplines, which comprise a high-reach and greatly understudied service sector.
The proposed project relies on the assistance of scalable digital mental health tools to support the
implementation of Motivational Interviewing (MI) to support help-seeking in real life (IRL; e.g., from trusted
adults, mental health service linkage) among youth helpline users. The community-partnered study will develop
and pilot an implementation strategy using human-centered design to preliminarily test its impact on a provider-
level mechanism (self-efficacy) and outcome (MI adherence), and patient-level outcome (help-seeking IRL).
The study will partner with Teen Talk App, a large helpline application that provides teen-to-teen emotional
support under the supervision of mental health staff. Aim 1 of the study will adapt MI to fit the service context.
Adaptations will tailor the innovation for delivery by teen peer helpers through brief text exchanges that
promote help-seeking IRL. Aim 2 will develop a multifaceted provider-level implementation strategy
(performance feedback and facilitated practice; PF-FP), which will be assisted by Artificial Intelligence (AI)
tools to support MI training. This will culminate in Aim 3, a pilot feasibility and acceptability trial, in which teen
peer helpers will receive MI training and then be randomized to receive PF-FP, or training as usual. The trial
will generate preliminary data on feasibility (using mixed methods data) and impacts of the implementation
strategy on the proposed mechanism and outcomes. The applicant is well suited to do this research given her
expertise in depression and suicide disparities, including developing cultural adaptations for minoritized youth,
but she requires the following additional training: 1) expertise in leading mixed-methods community-partnered
effectiveness-implementation hybrid trials; 2) expertise in training non-specialists in Motivational Interviewing
strategies; and 3) application of digital mental health tools, such as AI, to support scalable training of peer
helpers in MI. Mentorship and consultation from co-sponsors Drs. Anna Lau and Miguel Villodas (hybrid trials,
community-partnered human centered design, multilevel statistics), Dr. Lawrence Palinkas (mixed-methods in
implementation science) Dr. Elizabeth D’Amico (MI training and adaptation for non-specialist settings), and Dr.
Stephen Schueller (digital mental health) will facilitate this training.

Public health relevance
PROJECT NARRATIVE The objective of this proposal is to adapt, refine, and preliminarily test an implementation strategy to support the adherent use of adapted Motivational Interviewing by teen peer helpers within an existing text-based helpline. The proposed study has important public health implications given that it can provide information about how evidence-based interventions can be integrated at scale into mental health helplines, which currently reach millions of people a year and are a highly understudied service sector. Since youth of color with unmet mental health needs tend to access text-based helplines, results from this proposed study can reduce mental health access disparities.